Institutional Training Grant in Genome Science

We propose to continue the highly successful Stanford Genome Training Program (SGTP) for another five years, comprising the 28th to the 32nd year of the program. Since its inception, the SGTP has trained 224 Graduate Students and 79 Postdoctoral Fellows with outcomes of outstanding research contributions and publications, and many trainees later assuming careers in leadership positions in academia and industry. In this next funding period, we will continue to select and train exceptional students via extensive programs that include rigorous coursework, skill-building in computational and quantitative biology, training in the responsible conduct of research as well as in reproducibility and rigor, ethics, and other activities essential to scientific growth. After initial laboratory rotations, students will perform their thesis research in the laboratory of one of our 56 outstanding participating faculty, who hold primary appointments in 16 departments of four Stanford schools; the majority of these investigators have trained students or postdocs supported by the SGTP. Collaborations and interactions among faculty and students from different groups are commonplace and facilitate student success and interdisciplinary research. Our well-resourced laboratories and facilities enable the very best science in a wide range of genomics-related research areas. The Stanford School of Medicine is highly supportive with programs that foster general skills, well-being, and career advancement, and provides a highly interactive environment conducive to productive collaboration and communication. We will continue our efforts to provide a successful program with all individuals. We are enthusiastic to continue to train the next generation of science leaders and highly skilled researchers, exhibiting creativity, integrity, and productivity, both for academia and the private sector.

Public health relevance
Project Narrative The Stanford Genome Training Program trains PhD students and postdoctoral fellows to advance to productive technical and high-level leadership positions in the biomedical sciences, in academia and in the private sector. Specifically, we train the next generation of scientists in the field of genomics and related areas, which has become a centerpiece in understanding basic biology as well as disease diagnosis and prevention, due to tremendous technical advances and a confluence of computer science with biomedicine. Many of those advances were catalyzed and driven by our former trainees and those of similar institutions.